Mechanisms of lmmunosuppression in MYCN-driven Neuroblastoma

PROJECT SUMMARY
Enhanced MYCN activity drives the initiation, progression, and treatment resistance of multiple solid tumors,
especially those arising from the brain, the spinal cord, or neural crest. Neuroblastoma, derived from the
peripheral sympathetic ganglia, accounts for the second leading cause of deaths among children with solid
tumors. Like many other solid tumors, MYCN-driven high-risk neuroblastoma harbors an immunosuppressive
tumor microenvironment (TME), characterized by few cytotoxic lymphocytes and poor responses to
immunotherapy. Despite intensive efforts, the mechanisms through which MYCN promotes an
immunosuppressive TME remain incompletely understood and strategies to overcome this challenge are
lacking. We recently reported that MYCN-driven neuroblastoma increases the secretion of CKLF1, a chemokine-
like factor (CKLF) isoform, to recruit CD4+ cells to the TME, inducing immunosuppression and tumor
aggressiveness. Analyses of primary neuroblastoma samples demonstrate a strong connection between
MYCN, CKLF, and poor patient prognosis. The zebrafish model of MYCN-driven neuroblastoma simulates the
immune system and tumor development in children and resembles human high-risk disease. Overexpression
of cklf in the zebrafish neural crest attracts multiple immune cells, including CD4+ cells, to the TME as early as
the premalignant stage, which incites immunosuppression while promoting tumor initiation and metastatic
spread. On the other hand, depleting Cklf significantly inhibited MYCN-driven neuroblastoma initiation and
progression while reverting the pro-TME to an immunogenic one. We and others found that CKLF1 binds to CC
chemokine receptor 4 (CCR4), a cell surface receptor on CD4+ cells (e.g., Treg cells and macrophages). The
above evidence formulates our hypothesis: CKLF1 secreted by MYCN-driven tumor cells recruits and exploits
immune cells, particularly CD4+ cells, to induce an immunosuppressive TME and promote tumor aggressiveness,
thus representing a novel immunotherapeutic target. We will leverage the unique imaging and genetic capacities
of the zebrafish neuroblastoma model together with analyses of patient samples, in vitro co-culture systems, and
murine models to pursue three complementary yet integrated aims. In Aim 1, we will characterize the types
and properties of immune cells that CKLF1 recruits to the TME of MYCN-driven neuroblastoma. Experiments
proposed in Aim 2 will elucidate the mechanisms by which CKLF1 recruits and modulates CD4+ cells to induce
immunosuppression. In Aim 3, we will investigate the ability of inhibiting tumor-secreted CKLF1 to alleviate
immunosuppression and thus enhance immunotherapy responses. Our team’s combined expertise in
MYC/MYCN-driven neuroblastoma, tumor immunology, and single-cell transcriptomics technology is
ideal for the proposed research. Due to the wide involvement of MYCN in human cancers, information gathered
from our in-depth mechanistic studies and therapeutic strategy evaluation has the potential to apply to tumors
beyond neuroblastoma, for improved responses to immunotherapy.

Public health relevance
PROJECT NARRATIVE Most solid tumors, particularly neuronal cancers, respond poorly to immunotherapy due to their immunosuppressive microenvironment. This research focuses on in-depth mechanistic studies and therapeutic strategy evaluation for a newly identified chemokine in MYCN-driven high-risk neuroblastoma. The information generated from this study will deepen our understanding of how tumor cells repress immune clearance and serve as a rich resource to guide the development of improved immunotherapeutic strategies against neuroblastoma and other neuronal tumors.